PNNL PROTEOMICS AND THE UW P51 PRIMATE GENOME CENTER

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Apply PNNL high throughput comparative, quantitative proteomics for investigating disease states of non-human primates and their tissue pathologies as models for human disease.